Effects of Ethanol on TNF Cytotoxicity

DESCRIPTION (provided by applicant): Ethanol exposure promotes the development of alcoholic liver disease (ALD) but the mechanisms underlying ethanol-induced hepatotoxicity remain poorly understood. An important cellular site manifesting damage brought on by ethanol is the mitochondria. Proinflammatory cytokines such as tumor necrosis factor alpha (TNFalpha or TNF) have been linked to many of the associated damage and repair processes seen in ALD. TNFalpha prompts the opening of the mitochondrial permeability transition pore (MPT). The MPT is the regulatable opening of a large, nonspecific pore across the outer and inner mitochondrial membrane. Development of the MPT has been implicated in both necrotic and some forms of apoptotic cell death. Inhibition of the MPT prevents many of the typical manifestations seen during apoptosis. Liver mitochondria isolated from chronically ethanol fed rats are more susceptible to MPT pore opening induced by various triggers than mitochondria isolated from control animals. In preliminary results we demonstrate an enhancement of TNFalpha cytotoxicity in hepatocytes isolated from chronically ethanol-fed rats compared to their pair-fed controls. Similarly, a 48h exposure of HepG2 cells to ethanol enhanced susceptibility to TNFalpha cytotoxicity. The data suggest that ethanol enhances TNFalpha cytotoxicity, at least in part, by promoting the MPT. The general goals of this project are to investigate the mechanisms by which ethanol potentiates TNFalpha induced cytotoxicity. Our working hypothesis is that ethanol inhibits signaling pathways that protect against TNFalpha cytotoxicity and activates pathways that promote the mitochondrial permeability transition. This theory is supported by our preliminary observations that ethanol inhibits P13-kinase dependent BAD phosphorylation induced by TNFalpha and promotes cell death in a p38 MAPK dependent and caspase 8 independent manner. In addition, ethanol exposure sensitizes mitochondria to the MPT and causes an increase in the levels of the peripheral benzodiazepine receptor, a putative component of the MPT pore. Our SPECIFIC AIMS are to #1) further define the role of ethanol in the alteration of P13-kinase activity and its influence on TNFalpha cytotoxicity and #2) delineate the role and mechanism(s) of activation of p38 MAPK in ethanol plus TNFalpha cytotoxicity; #3) Define the mechanism(s) by which TNF plus ethanol cause the MPT.